Deciphering the Role of Mycobiome (Fungus) in Lung Carcinogenesis

The role of 'polymorphic microbes' in cancer development and progression has been extensively studied, but
research on the role of fungi (mycobiomes) is surprisingly limited. To address this gap, we have developed an
innovative 3D-organotypic lung (iLung) model derived from human pluripotent stem cells (hPSCs). This model
in combination with live spore-based exposure/infection methods, allows for the study of direct contact between
epithelial cells and pathogens in the culture media, providing more accurate representation of real-life exposure,
infection, and intratumoral colonization.
Using this model, the team has demonstrated extensive DNA damage and identified specific DNA breakage
motifs and mutational signatures in lung cells infected with spores of Aspergillus fumigatus (Asp), a common
fungal pathogen found in human airways and lung cancer samples. Notably, significant mutations were observed
in important cancer genes, and lung cancer lines treated with Asp showed more advanced and aggressive tumor
phenotypes. The team also noticed increased levels of IL-33 and other type 2 cytokines, IL-4, IL-5 and IL-13,
known regulators of Th2-type immune responses, in treated cells. These preliminary studies led to the hypothesis
that mycobiomes can promote malignancy either directly, by inducing mutations, or indirectly, by reshaping host
immune responses. The team proposes to test this hypothesis using the hPSC-derived iLung system, live spore-
based infection models, and advanced technologies such as identification of mutational signature, single-cell
transcriptomics, and molecular modeling using quantum mechanics calculation.
The research project is centered on three aims. The first aim is to establish the carcinogenic effect of fungi on
lung cancer, particularly focusing on Asp and other common fungal species (e.g. Alternaria) in lung cancer. The
second aim is to understand the mechanism of fungal mutagenesis, examining both direct and indirect routes,
such as the role of mycotoxins and the increase of reactive oxygen species (ROS). The third aim is to determine
the effect of fungus-induced remodeling of host immunity in lung cancer. The research's expected outcome is to
illuminate the mechanisms by which fungi contribute to cancer development and progression. This could pave
the way for the development of novel diagnostic, preventive, and therapeutic strategies against cancer influenced
by mycobiomes.

Public health relevance
The influence of microbiomes on cancer development is gaining attention, yet the role of fungi (mycobiomes) in cancer remains largely unexplored. In this project, we have developed a novel 3D-organotypic lung (iLung) model derived by differentiation of human pluripotent stem cells, that better represents real-life exposure, using live fungal spores. In combination with a range of advanced technologies, including mutation calling and signature identification, single-cell transcriptomics, and quantum mechanics calculation, we aim to test the hypothesis that mycobiomes can enhance cancer development either directly, by causing mutations, or indirectly, through reshaping host immune responses.